Role of cellular long non-coding RNAs in HIV replication and disease outcome

Summary
The majority of the human transcriptome consists of long non-coding RNAs (lncRNAs), which regulate the
expression and function of protein-coding genes, immune cell development, differentiation, and response to
pathogens. Infections induce global changes in lncRNA expression. The expression of lncRNAs in HIV-infected
cells and how host lncRNAs impact the replication and persistence of HIV infection are unknown. A spontaneous
functional cure of HIV-1 occurs in 0.3-0.5% of all HIV patients. These patients, termed elite controllers (EC),
maintain undetectable levels of HIV in the absence of treatment, maintain stable CD4+ T cell counts, and are
less likely to transmit HIV. The ECs exemplify spontaneous control of HIV, and identifying defense mechanisms
in these patients holds promise for finding a functional cure for HIV infection. Previous studies focused on protein-
coding genes. However, effective HIV control is likely to involve complex gene networks, including lncRNAs. We
found several lncRNAs significantly suppressed in EC vs. HAART-treated chronic HIV-patients and healthy
uninfected controls. The functional impact of lncRNAs suppressed in EC (SIEC) on HIV outcomes is unknown.
We have observed significant global changes in cellular lncRNA expression in HIV-infected CD4+T cells
compared to uninfected cells in our preliminary studies. Cellular functions of most of the HIV deregulated (HIDE)
lncRNAs are yet to be determined. We employed a CRISPR/RfxCas13d (CasRx)-silencing screen to determine
the functional impact of SIEC and HIDE lncRNAs on HIV replication. Our preliminary data showed that silencing
of several SIEC and HIDE lncRNAs significantly regulated HIV replication. Based on these preliminary data, we
hypothesize that host lncRNA expression in HIV-infected cells orchestrates natural resistance and disease
outcome in HIV infection. We will determine how the suppression of specific lncRNAs in ECs is protective and
elucidate molecular mechanisms of their function (Aim 1). We will also identify HIV deregulated (HIDE) lncRNAs
modulating viral replication and investigate the mechanism(s) underlying lncRNA-mediated regulation (Aim 2).
We will pursue these aims using innovative combinations of molecular and biochemical techniques, such as
CRISPR/CasRx-silencing, transcriptomics, RNA antisense purification, and Mass-Spectrometry in cell line
models as well as primary CD4+ T cells. The proposed research is significant because it will identify cellular
lncRNAs that influence spontaneous control of HIV and disease outcomes, deliver unprecedented insight into
lncRNA-mediated regulation of HIV replication, lay the groundwork for the development of new approaches to
intervention.

Public health relevance
Narrative This proposal aims to identify host lncRNAs that influence viral replication, disease outcomes, and molecular mechanisms of their action. The outcome from the study outlined in this proposal is identifying lncRNAs that regulate HIV propagation and contribute to the spontaneous control of HIV infection. The results will have a significant positive impact immediately as they will provide a better understanding of lncRNAs in HIV infection and disease outcomes, discover novel host factors that will be further evaluated for therapeutic potential.